NHGRI/DIR Medical Genetics Training Programs

The Medical Genetics Training Program is responsible for training physicians and Ph.D.level scientists in clinical genetics, molecular genetics, clinical and medical biochemical genetics and cytogenetics to become Board eligible to sit for the certification exam offered by the American Board of Medical Genetics. The Medical Genetics Training Program includes: the Metropolitan Washington DC Medical Genetics Residency Program, the Metropolitan Washington DC Medical Genetics Fellowship Program, the Metropolitan Washington DC Medical Biochemical Genetics Residency Program, the NIH/Children's National Medical Center Combined Pediatrics Medical Genetics Residency Program. These programs provide training for MDs and or Ph.Ds who seek Board certification in Clinical Genetics, Cytogenetics, Molecular Genetics, Clinical Biochemical Genetics and Medical Biochemical Genetics. Since 1997 we have trained over 140 fellows in these specialties. Training sites include the NIH, Children's National Medical Center(CNMC), Walter Reed Army Medical Center, Washington Hospital Center, Quest Diagnostics and GeneDx. Other sites including Johns Hopkins, University of Maryland Medical Center, the Maryland State Newborn Screening lab and the Biochemical Diagnostics lab at CNMC are elective training sites for Fellows with specific interests. The Clinical, Biochemical Genetics and Pediatric/Medical Genetics Fellows hold full time positions at the National Institutes of Health. Individuals enrolled in the Molecular Genetics and Cytogenetics program have salaries from their labs while they train under the Program/NHGRI supported infrastructure. NHGRI supported infrastructure includes faculty, laboratory settings with budget for disposables, course materials, travel allowance for scientific meetings and books. This program is nationally recognized for both its depth and breadth of training in genetics as well as the number of trainees it has produced. The elite research setting of the National Institutes of Health also provide Fellows with a unique opportunity to do research during their training optimizing their potential to be future leaders in the world of genetics.